STRESS, COPING AND PERSONALITY IN AGING MEN AND WOMEN

This project is concerned with the effects of stressors, coping mechanisms, and enduring personality dispositions on psychological and health outcomes. One study examined the long- term consequences of widowhood in the NHANES-I Followup Study; although there were significant changes in lifestyle, older men and women showed psychological resilience in adapting to bereavement. A six-year longitudinal study of personality in the BLSA provided new evidence of stability for all five major dimensions of personality in both self-reports and spouse ratings, and a study of depressive symptoms in a national sample showed that initially depressed individual are about five times as likely as others to be depressed after a ten-year interval. Studies using the NEO Personality Inventory employed a new method of factor rotation to define measures of the five major dimensions of personality with maximal construct validity; these factors were then used to classify the psychological needs measured by Jackson's Personality Research Form, and to interpret the indices of the Myers-Briggs Type Indicator. Three studies of health and behavior found that depression does not seem to be a risk factor for cancer; demonstrated the importance of severity ratings for perimenstrual distress; and identified Agreeableness-Antagonism as the personality dimensions most relevant to ratings of Potential for Hostility, predictor of CHD.